The Role of Puberty in Corticostriatal Circuitry Development and Avoidance in Adolescents with Anxiety

Summary
Nearly one in three youth are diagnosed with an anxiety disorder during childhood or adolescence, which often
persists into adulthood and increases the risk of depression and suicide. Early adolescence, with the onset of
puberty, coincides with sex differences in the rise of anxiety symptoms, particularly social and generalized anx-
iety disorder. During this time, corticostriatal circuitry implicated in reward processing and learning (ventral teg-
mental area [VTA], nucleus accumbens [NAcc], ventromedial prefrontal cortex [vmPFC]), undergo significant
maturation and are altered in individuals with anxiety disorders. Yet, how puberty impacts development of this
circuitry in anxious youth remains unclear. Avoidance of perceived threat is a core symptom of anxiety. Rein-
forcement learning (RL)—learning from expectation and outcome—is supported by corticostriatal circuitry and
provides a compelling framework to understand avoidance. Computational modeling of fMRI data with RL tasks
indicates that individuals with anxiety disorders exhibit reduced reward prediction error—dopaminergic striatal
signal to unexpected reward. Similar PE signaling patterns are present in women but the neurobiological mech-
anisms underlying the emergence of these sex differences are unknown. Animal studies show that gonadal
hormones sculpt and modulate corticostriatal circuitry implicated in reward learning. Thus, it is plausible that rise
in pubertal hormones could impact corticostriatal function but how blunted reward PE signals translate into daily-
life approach-avoidance behavior in anxious teens is unclear. We will test the overarching hypothesis that
blunted reward PE signaling within the striatum/vmPFC will be associated with more frequent avoidance/less
approach behavior and anxiety symptoms and that the rise in pubertal hormones will amplify this relationship,
especially in girls. We test this hypothesis in 140 unmedicated adolescents (50% female), varying in levels of
anxiety, with 2/3 oversampled for clinical levels anxiety symptoms. We will repeatedly assess participants at five
timepoints. At baseline and approximately 18 months later, we will assess anxiety (clinical interviews, question-
naires), pubertal status (Tanner, self-report), pubertal hormones (DHEA, testosterone, and estradiol), approach-
avoidance behavior in the lab and daily life (i.e., Ecological Momentary Assessment), and indices of corticostri-
atal circuitry function (passive avoidance fMRI task, resting state fMRI, dopamine function, measures of gluta-
mate and GABA). We use multimodal neuroimaging with ultra high-field MRI at 7 Tesla, which will yield unprec-
edented characterization of corticostriatal neurodevelopment during puberty in anxious youth. Change in symp-
toms will be assessed bi-annually via online questionnaires over 18 months post-baseline visit. We aim to: 1)
Characterize corticostriatal circuitry implicated in RL in anxious adolescents; 2) Determine how pubertal hor-
mones are associated with corticostriatal function development, daily-life avoidance/approach behavior, and
anxiety; 3) Explore associations between neural indices of corticostriatal function and wholebrain networks.

Public health relevance
Narrative The prevalence of anxiety disorders among U.S. teens has surged over the past decade, with one in four adolescents being diagnosed by age 18 and symptoms drastically increasing during early adolescence with the onset of puberty, especially in female teens rendering them at heightened risk for depression. This longitudinal study will investigate in anxious teens how pubertal hormones impact brain circuitry involved in reward learning and avoidance behavior—a key symptom of anxiety disorders—and examine sex differences in these effects along with links to anxiety symptoms and approach-avoidance behavior in daily life. The findings could reveal brain changes during puberty that inform personalized interventions for anxious teens.